Mosaic: RCT of a Digital Health Intervention Delivering Peer Support Narratives and Psychoeducation to English- and Spanish-Speaking Stem Cell Transplant Recipients

Cancer patients undergoing hematopoietic stem cell transplant (SCT) face numerous challenges because of this
treatment’s toxicity, lengthy hospitalization and recovery, and persistent medical and psychosocial stressors.
Patients describe needing more information and support to help them manage distress, medical symptoms, and
poor quality of life; feel prepared for SCT; and adhere to critical post-SCT preventive behaviors. Patient education
from healthcare providers is a critical information resource, but patients also describe wanting information from
other patients and needing types of information and emotional support that are best provided by people who
have undergone SCT (i.e., peer support) including realistic information about the experience of treatment and
recovery, side effects, and ways of coping. Peer support can reduce distress and social isolation; increase hope
and optimism; help patients feel more informed, empowered, and prepared; normalize their reactions and
experiences; alert them to available resources; support and inform decision making; and model new ways of
problem solving and coping. Research shows that cancer patients have limited access to peer support, which is
challenging to provide in a scalable, cost-effective way. In the prior project period for this award (R01CA223963),
we developed a website (called Mosaic) in both English and Spanish to deliver peer support to SCT recipients
through a collection of first-hand, survivor-written narratives paired with coordinated educational content and
stress/coping resources. Developed with extensive guidance from a community advisory board, focus groups,
usability testing, and a strong theoretical foundation, Mosaic was designed to be scalable, easily accessible, and
able to help patients understand a range of SCT experiences in a way that is tailored to their emotional and
problem-focused coping needs. Mosaic is now ready for efficacy testing. We propose a 2-arm randomized
controlled trial to evaluate whether providing patients with Mosaic prior to SCT can reduce their psychological
distress (primary outcome) and improve other patient-reported and clinical outcomes. We will randomize 356
English- and Spanish-speaking patients recruited pre-SCT to Mosaic or to a rigorous web-based enhanced usual
care condition that includes only Mosaic’s educational content. Participants will complete assessments at pre-
SCT baseline, and 2-, 4-, 6-, and 8-months post-SCT. The trial will allow us to achieve 3 aims: (1) establish
Mosaic’s efficacy for improving patient-reported outcomes of English and Spanish-speaking SCT patients; (2)
determine mechanisms driving Mosaic’s effect on patient-reported outcomes; and (3) examine moderators of
Mosaic’s effects on patient-reported outcomes. We will also use rich qualitative methods to explore patients’
experiences of whether and how Mosaic affected preventable clinical SCT outcomes with the goal of informing
more focused, rigorous future research on these mechanisms. If efficacious, Mosaic could be quickly
implemented clinically to reduce distress and improve outcomes in SCT.

Public health relevance
This proposal supports the NCI’s public health goal of improving the quality of survival of persons diagnosed with cancer and the goal of preventing, minimizing, or managing adverse effects of cancer and its treatment. It does so by advancing evaluation of a novel intervention that pairs a collection of first-hand, survivor-written peer support narratives with coordinated educational content and stress/coping resources for hematological patients preparing for, undergoing, and recovering from hematopoietic stem cell transplant. If successful, this research would yield a low-cost, scalable intervention that fills a gap in supportive resources for transplant recipients.